Translating near infrared autofluorescence for guiding pediatric endocrine neck surgeries

Project Summary
This proposal aims to address the rate of hypocalcemia following thyroidectomy in the pediatric population using
near infrared autofluorescence (NIRAF) of parathyroid glands. Thyroid cancer is one of the most common
cancers affecting adolescents and young adults and permanent hypoparathyroidism is the most frequently
reported complication following thyroidectomy. Post-operative hypoparathyroidism (PoSH), resulting from
damage to the parathyroid glands or their vasculature, gives rise to hypocalcemia in 30-50% of cases transiently
and up to 7% permanently. We have developed an approach based on NIRAF exhibited by the parathyroid
glands and demonstrated clinical utility by showing that 97% of parathyroid glands have greater autofluorescence
than surrounding tissues. The lab-built system used in these studies has since been commercialized as the FDA
cleared PTeye® marketed by Medtronic. However, additional work has shown the autofluorescence from other
neck tissues are more variable in the pediatric population, causing a higher false positive rate. Here, we propose
a rigorous evaluation of the autofluorescence of pediatric neck tissues to aid in the specific translation of this
technology to pediatric neck surgeries by tailoring the metrics used for this new patient population. To achieve
this, we will characterize the spectral properties of parathyroid gland tissue in children (Aim 1) at five of the
nation’s high-volume centers for pediatric thyroidectomies. The variation of NIRAF over time in the pediatric
population will then be interrogated using parathyroid gland organoids (Aim 2) to better understand the
underpinnings of the fluorescence signal. Finally, the findings from Aims 1 and 2 will be used to modify the
PTeye® before deploying it in the clinic to characterize the short- and long-term outcomes of pediatric
thyroidectomy among high-volume centers (Aim 3). Because this will be the first multi-center prospective study
for pediatric thyroidectomies, Aim 3 will also serve to standardize the perioperative care and clinical outcome
definitions, as current practice is extrapolated from adult procedures without pediatric-specific clinical standards.

Public health relevance
Project Narrative Near infrared autofluorescence (NIRAF) has arisen as an optical modality for ensuring parathyroid glands remain intact during and after thyroid gland removal in adult patients, but what little study has been conducted on its use in children has shown the NIRAF in this population is significantly weaker and more variable than in adults. This proposal seeks to study how NIRAF behaves in children both with respect to age and physical development, modify current clinical device so it can be used in children and conduct a clinical trial to ensure accuracy and standardization of such surgeries.